Training in Environmental Toxicology

PROJECT SUMMARY/ABSTRACT
The Joint Graduate Program in Toxicology (JGPT) is an interdepartmental training program in mechanistic
toxicology at Rutgers University. Founded in 1981, the JGPT has trained more than 200 doctoral students,
postdoctoral fellows, and clinician scientists. Graduates of the JGPT have established distinguished careers in
academia, industry, and government. The NIEHS T32 training grant is the driving force of the JGPT. This
competitive renewal application requests funding for years 36-40 to support 8 predoctoral students and 3
postdoctoral fellows each year. The central mission of the JGPT is to provide talented and motivated
predoctoral and postdoctoral trainees with rigorous didactic and laboratory training in contemporary
mechanistic toxicology and in-depth expertise in their individual field of research. The program is highly
interdisciplinary with students performing research rotations under scientists from varied scientific
backgrounds. Training is supported by an exceptional research environment centered at the Environmental
and Occupational Health Sciences Institute (EOHSI) that includes state-of-the-art instrumentation and
collaboration that synergizes with our NIEHS P30 Center of Excellence in Environmental Health Sciences.
Rutgers University has designated “Environmental Health Sciences” a Signature Program. This affords our
program strong institutional support with significant investment in research, training, and new faculty
recruitment. JGPT trainees benefit from an outstanding seminar series and strong participation by leading
scientists from the local pharmaceutical, chemical and personal care products industry. Intensive efforts are
expended to attract students and fellows of exceptional quality with prior research experience from diverse
scientific disciplines. The JGPT vigorously recruits and retains students from underrepresented groups using
multiple outreach initiatives. Trainee accomplishments include high research productivity, strong publication
and fellowship records, job placement, and honors and awards from professional organizations. The JGPT
adapts to advances in the field of toxicology using comprehensive outcomes assessment and plans are for the
program to undergo an external review by an education evaluator during the next funding cycle.
RELEVANCE: The unifying goal of the JGPT and this training grant is to prepare trainees to excel in the
competitive and rapidly evolving arena of environmental health sciences. Toxicology is a core discipline in
understanding the impact of chemicals on human health. For the last 35 years, this training grant has enabled
Rutgers to educate scholars who have become leaders in academic, industrial, and governmental toxicology.

Public health relevance
PROJECT NARRATIVE The Joint Graduate Program in Toxicology (JGPT) is a training program designed to instruct doctoral students, postdoctoral fellows, and clinician-scientists in the field of mechanistic toxicology. Trainees study how chemicals in the environment cause disease in people and develop strategies to prevent or treat these illnesses. Comprehensive laboratory and classroom training prepares toxicologists from the JGPT to address emerging environmental health issues confronting our society.